Awarding of travel grants to early-career clinician scientists to attend the Association for Research in Vision and Ophthalmology annual meeting (2018-2022).

Renewal Application
ARVO Annual Meeting
5 U13 EY02143
Project Summary/Abstract
The Association for Research in Vision and Ophthalmology (ARVO) annually conducts the principal
international eye research meeting. Over 11,000 eye and vision researchers attend this meeting, which is
held in cities throughout the United States. Nearly 6,500 researchers submit scientific abstracts describing
their recent eye and vision research findings. Of these, over 6,000 abstracts are accepted for presentation
in paper and poster sessions during the five-day meeting. Participation in the ARVO meeting remains
strong, regardless of funding levels and economic conditions.
After 18 year in Fort Lauderdale, Florida, the ARVO Annual Meeting began rotating to a variety of U.S.
and Canadian cities, allowing researchers from around the world access to the Meeting. The ARVO
Annual Meeting is targeted to clinical practitioners, research scientists, medical education professionals,
and students-in-training from a variety of disciplines. Nearly 40% of participants each year are students-
in-training; this number mirrors the percentage for abstract submitters as well. The research objectives of
the programs of the National Institutes of Health and of the National Eye Institute, including the
Audacious Goals program, are well-represented in the Annual Meeting programs and in individual
presentations. The research presented at the ARVO Annual Meeting represents the latest developments in
understanding, diagnosing, preventing and treating the many sight-threatening diseases and conditions.
This meeting is of particular importance in the development of new and early-career investigators, as it
provides not only a forum for presentation and critical analysis of their work, but also an informal setting
in which they can discuss their research problems. By associating with the leaders in the field, new and
early-career investigators can see the value of continued dedicated research efforts.
The overall objective of this grant is to provide travel grant awards that cover partial support for travel
and hotel to attend the ARVO Annual Meeting for those new and early-career investigators who
demonstrate potential for future success as eye and vision researchers and whose research findings are
accepted for presentation at the Meeting are considered to be of high interest to the ophthalmic research
community. This grant will provide travel funds for 70 investigators each year from 2018 to 2022. The
meeting dates and locations for the ARVO Annual Meeting are:
April 29 – May 3, 2018 Honolulu, Hawaii
April 28 – May 2, 2019 Vancouver, Canada
May 3-7, 2020 Baltimore, Maryland
May 2-6, 2021 San Francisco, California
May 1-5, 2022 Denver, Colorado

Public health relevance
Renewal Application ARVO Annual Meeting 5 U13 EY02143 Project Narrative The Association for Research in Vision and Ophthalmology (ARVO) Annual Meeting serves as a forum for presenting cutting edge research on the leading causes of blindness and vision impairment, on the prevention of visual loss, and on development of clinical therapies that can alleviate the progression of vision diseases and disorders affecting Americans. The 2014 annual cost for vision disorders in the U.S. was $145 billion and is projected to grow to $373 billion by year 2050−or $717 billion in inflation- adjusted dollars. The direct medical costs of vision disorders are the fifth highest−only less than heart disease, cancers, emotional disorders, and pulmonary conditions. The first wave of the 78 million Baby Boomers−also called the “Silver Tsunami”− started turning age 65 in 2010. Each day, for the next 18 years afterward, 10,000 Americans will turn age 65 and be at greatest risk for age-related eye diseases.